Calprotectin and Antibiotic Activities at the Infection Interface

Calprotectin is the most abundant protein in neutrophils. Our surprising discovery that calprotectin can
bind and hydrolyze multiple β-lactam antibiotics forms the basis of this proposal. In particular, calprotectin
hydrolyzes and inactivates the penicillin sub-class that includes ampicillin, amoxicillin and oxacillin, which are
among our most important and most widely used antibiotics. The identification of calprotectin as the first known
host protein with β-lactamase activity has major implications for the treatment of infection. Indeed, our
preliminary data demonstrate that human neutrophils hydrolyze β-lactam antibiotics in tissue culture and that
oxacillin treatment is more effective in calprotectin-deficient mice than in wild-type mice.
In Aim 1, we will determine the impact of calprotectin’s β-lactamase activity on antibiotic efficacy in vivo
through three sub-Aims. We will first assess the ability of calprotectin to hydrolyze β-lactams during E. coli and
S. aureus infection in mice. We will determine how the β-lactamase activity of calprotectin alters antibiotic-
mediated growth inhibition and killing of pathogens during bacteremia and wound infection. We have shown
that the serine β-lactamase inhibitor, sulbactam, blocks the β-lactamase activity of calprotectin. Therefore, we
will next examine the capacity of various approved β-lactamase inhibitors to inhibit the β-lactamase activity of
calprotectin and determine the capacity of inhibitors to improve β-lactam efficacy in mice, against penicillin
sensitive bacteria, lacking any native β-lactamase production. Finally, we will assess whether β-lactam binding
or inhibition of β-lactamase activity of calprotectin affects the innate immune functions of calprotectin, including
metal sequestration and TLR4 activation.
In Aim 2, we will elucidate the molecular mechanism(s) of calprotectin’s β-lactamase activity through
two sub-Aims. Our preliminary evidence suggest calprotectin has multiple β-lactam binding sites and binds β-
lactams with a high affinity. We will first fully characterize the β-lactamase activity of calprotectin, including
dependence on parameters such as metal ions, salts, pH, temperature, and multimeric state. We will test
hypotheses concerning reaction mechanism through enzymatic characterization of site-directed mutants. We
will complement kinetic methods by determining the co-crystal structure of calprotectin bound to various
inhibitors of β-lactamase activity.
The completion of our Specific Aims will comprehensively characterize the newly discovered β-
lactamase activity of calprotectin, determine its contribution to antibiotic efficacy in vivo and identify new
avenues for drug development. Our proposal is significant due to potential impact on multiple aspects of
treatments for bacterial infections. Our proposal is conceptually innovative in establishing a new paradigm for
how calprotectin affects the outcome of bacterial infection.

Public health relevance
Calprotectin is a metal binding, innate immune protein that accumulates at extremely high levels at the site of infection. We discovered that calprotectin has enzymatic activity that leads to the inactivation of -lactam antibiotics, including ampicillin, amoxicillin, and oxacillin. Here, we propose to measure how calprotectin mediated antibiotic inactivation affects antibiotic treatment of infected mice, while also elucidating the molecular mechanism of -lactam inactivation.